Targeting microRNAs to modulate neutrophil trafficking and improve resolution of gut inflammation.

Neutrophil activity in tissues can exacerbate inflammation and promote tissue damage, as seen in inflammatory
bowel diseases (IBD). Thus, studies focused on PMN trafficking are of continued interest and physiological
significance. Crossing of the endothelial cell (EC) barrier is the first critical regulatory step in tissue PMN effector
function and targeting existing and novel signaling molecules/pathways involved in this process is an attractive
therapeutic strategy. miRNAs-focused therapies are an exciting emerging field, with several miRNA therapeutics
already approved for clinical use and more being tested in clinical trials. Identification of miRNAs has been
acknowledged by the 2024 Nobel Prize in Medicine, highlighting their significant impact and potential as
therapeutics. As such miRNAs present an exciting opportunity for therapies, as their expression can be easily
manipulated using synthetic miRNA mimics or antagonists, which can be synthesized as cell permeable
molecules with superior tissue uptake. miRNAs broadly regulate many biological processes and have been
implicated in IBD pathogenesis and heightened immune response. Specifically, miRNAs can regulate
organization of the actin cytoskeleton, cell polarity, cytokine/chemokine signaling and cell adhesion, all of which
are critical regulatory process of neutrophil transendothelial migration (TEM).Thus, in the current studies we
propose to perform an unbiased miRNA profiling in circulating PMNs in clinically relevant infectious, salmonella-
induced and DSS-induced colitis/injury models followed by phenotypical and functional target validation with the
goal of 1. Identifying novel microRNAs that regulate PMN TEM in gut inflammation and 2. Establishing whether
manipulating miRNA activity can effectively suppress PMN TEM and improve resolution of gut inflammation. In
preliminary work we established the premise for targeting reduction in neutrophil migration and tissue
accumulation to improve disease outcomes in these models. We also optimized all relevant protocols for blood
neutrophil isolation and mRNA sequencing.
These high-risk-high-reward studies are well suited for the R21 funding mechanism as they provide a platform
for the development of novel interventions, such as miRNA therapeutics, aimed at regulation of PMN crossing of
the vascular wall and trafficking into tissue, which will help achieve important clinical endpoints, including
resolution of mucosal inflammation and wound healing.

Public health relevance
Neutrophil crossing of the vascular wall is the first critical regulatory step in controlling their protective functions against pathogens or pathological roles in IBD. We aim to use preclinical murine models of gut inflammation and unbiased molecular profiling, followed by phenotypic and functional validation to identify novel microRNAs that regulate neutrophil migration in gut inflammation, and establish whether manipulating miRNA activity to effectively enhance/suppress neutrophil trafficking can be used as therapeutic strategies to improve pathogen clearance and/or promote resolution of gut inflammation.